Photobiomodulation for the management of Temporomandibular disorder pain

Project Summary/Abstract
Given the paucity of effective treatments for TMD and the overuse of pain medication, well-designed studies are
needed to evaluate non-pharmacological alternatives to treat this common and disabling chronic pain condition.
Our goal in this study is to conduct a double-blind, sham-controlled, randomized clinical trial of multimodal
Photobiomodulation (PBM) for TMD pain. Also, we propose to determine if PBM-induced changes in
inflammation and pain sensitivity contribute to PBM’s analgesic effects. A total of 130 TMD participants will be
recruited through community-based advertisements. Participants will complete a computer-assisted telephone
screening (CATI). Eligible participants will be age 18 and older with pain intensity of ≥30 on a visual analog scale
(0-100). Participants will be excluded if: a) starting a new daily prescription medication for the management of
pain within 30 days before CATI; b) use of injection therapy (e.g., tender or trigger point injections, steroid
injections) for the management of pain within 2 weeks before the CATI; c) starting occlusal appliance therapy
within 30 days before CATI; d) history of facial trauma or orofacial surgery within 6 weeks before CATI; e) active
orthodontic treatment; f), psychiatric hospitalization within one year before the screening. Participants eligible
after CATI will be scheduled for a pre-randomization visit (V0), eight treatment visits (V1 to V8), one post-
treatment visit (V9), an internet/ phone follow-up at 1 and 3 months, and six-month follow-up clinical visit (V10).
V0 will include informed consent, completion of a detailed medical history and to assess clinical pain and
interference, participants will complete the Pain, Enjoyment, General Activity (PEG) Scale followed by a clinical
exam to confirm TMD status according to the Diagnostic Criteria for TMD (DC/TMD), Pressure Pain Sensitivity
(PPT) and blood draw. V1 will be the randomization visit to either receive PBM or Placebo. V2-V8 are treatment
visits. V5 is also the Midway visit, therefore, a blood draw, DC/TMD exam and PPT will be performed before
treatment. At V9 (post-treatment visit), post-treatment outcomes will be assessed, PEG, DC/TMD exam, PPT
and a blood draw. PBM/Placebo treatment: We will use three types of active/Placebo probes; A) Single Laser
808 nm, 4.75W/cm 2; B) Laser Cluster, five x 810 nm, 5.96W/cm 2 and four LED 660nm, 0.05W/cm 2and; C) LED
Cluster, 56 X 660nm 0.51W/cm2 and 48 850nm, 0.45W/cm2, 950mW total applied to multiple craniofacial sites.
Analyses will determine treatment effects on the primary outcome (pain intensity) and multiple secondary
outcomes and will examine, exploratorily, whether changes in inflammation and pain sensitivity mediate
treatment response. Findings from this rigorously designed trial will provide the most definitive evidence to date
regarding the effectiveness and mechanisms of PBM for treating TMD pain.

Public health relevance
Narrative Previous evidence regarding the efficacy of photobiomodulation (PBM) in the treatment of temporomandibular disorder (TMD) is inconclusive due to methodological weaknesses. Our goal is to conduct a rigorous, double- blind, sham-controlled, randomized clinical trial of multimodal PBM therapy for pain related to TMD. Also, we propose to determine if PBM-induced changes in pain sensitivity and inflammation contribute to PBM’s analgesic effects.